Podocyte-specific Rap1 agonism for treatment of glomerular disease

Project Summary/Abstract:
The incidence of proteinuric kidney diseases are increasing with well over 500 million cases worldwide.
Over the last two decades, it has become clear that specialized kidney cells, called podocytes, regulate
kidney filtration and are injured in all forms of proteinuric diseases regardless of etiology. Despite this,
targeted effective therapies that protect podocytes and slow chronic kidney disease progression are
completely lacking. Previously, we reported that the small GTPase Rap1 regulates fundamental
biological processes in podocytes by cycling between inactive GDP-bound and active GTP-bound forms.
We demonstrate that the podocyte Rap1 activation state is controlled by many upstream factors, both
positive and negative, that converge to control the ratio of GTP- and GDP-bound forms. The essential
role of these upstream regulators is emphasized by the presence of human familial nephrotic syndrome
caused by mutations to several of these genes, including newly identified gain of function mutations in
the negative Rap1 regulator, Rap1GAP. Each of these mutations has in common that they cause relative
depletion of podocyte Rap1-GTP. In the current proposal, we show that levels of podocyte Rap1-GTP
are also diminished in human glomerular diseases including in diabetic kidney disease (DKD).
Augmenting levels of podocyte Rap1 activation genetically or pharmacologically protects podocytes in
short term injury models. By targeting podocyte-specific upstream Rap1 regulatory pathways, we are
developing novel Rap1 agonist compounds that activate Rap1 in podocytes, but not in other cell types.
Such an approach allows for podocyte-specific pharmacological Rap1 activation and avoids potential
systemic toxicities. The goals of the current grant are to explore the therapeutic potential of Rap1
agonists in podocyte diseases including in DKD. We accomplish this via three specific aims: i) Test
whether enhanced podocyte Rap1 activation will mitigate chronic glomerular injury utilizing novel
inducible podocyte-specific constitutively active Rap1 transgenic mice. ii) Characterize the glomerular
phenotype of a novel Rap1GAP knock-in mouse model that expresses a double missense Rap1GAP
human disease-associated variant and then utilize both novel mouse models to elucidate specific Rap1
downstream effectors that establish podocyte injury susceptibility versus protection. iii) Synthesize
podocyte-targeted Rap1 agonist compounds and screen their ability to rescue podocyte injury in
transgenic Rap1-GTP deficient zebrafish. The efficacy of lead compounds will be tested in mouse
models of kidney disease including in DKD. Our current lead compound, BT-529, a Rap1-Rap1GAP
interaction antagonist, induces Rap1 activation in podocytes but not in other kidney cells and
dramatically protects cultured podocytes from injury. Overall, this work sets the stage for urgently needed
new podocyte-targeted therapies for kidney diseases.

Public health relevance
Project Narrative: Current therapies for glomerular diseases including diabetic kidney disease are non-targeted and offer limited therapeutic benefit, which has created a tremendous unmet clinical need. In the current proposal, we show that enhancing levels of Rap1 activation in specific kidney cells, called podocytes, protects them from injury and mitigates disease progression. As a novel therapeutic approach, we have developed Rap1 agonist compounds that specifically target podocyte-enriched upstream Rap1 regulatory elements, allowing for potent Rap1 activation in podocytes but avoiding potential off-target effects.